The iD2: A Smart Eye Drop Cap Monitor for Eye Drop Adherence

Project Summary/Abstract
Most patients with a diagnosis of glaucoma use eye drops to lower intraocular pressure. However, poor
adherence to prescribed eye drop regimens can lead to significant loss of vision-related quality of life. The
proposal will further develop the iDrop Device (iD2), a device-on-cap electronic platform designed to accurately
track when a research participant removes an eye drop bottle cap, wirelessly communicate usage data to a
database accessible to researchers, and send on-demand alerts when a medication is due. A device capable of
tracking eye drop usage and sending dosage alerts will test the hypothesis that electronic reminders improve
medication adherence and help research subjects improve their eye drop taking behavior. While our primary
focus is on glaucoma adherence, this device could also benefit those with other chronic eye conditions requiring
regular eye drop treatment, such as dry eyes, corneal endothelial disease, eye infections, and uveitis. This Direct
Phase II application proposes several improvements through electrical engineering enhancements, software
upgrades, and industrial design refinements. These advancements will help develop the next generation of the
iD2 device, which will be tested in a clinical trial. The trial will involve glaucoma patients with poor adherence
and will evaluate the effectiveness of the iD2 in improving medication adherence, as well as gather variables
that predict adherence. By the end of the proposal, we will have a commercially available, universal device that
accurately and reliably tracks eye drop usage. The device will be marketed to researchers, pharmaceutical
companies, remote patient monitoring companies, health plans, and insurance payers who are interested in
enhancing the quality of adherence data, and monitoring eye drop usage remotely. If successful, future versions
of the device will be designed and marketed for all patients who need to use eye drops consistently.

Public health relevance
Project Narrative Poor adherence to eye drop regimens occurs in a large proportion of patients with a diagnosis of glaucoma. The proposal will develop the iDrop Device (iD2), a monitor to accurately measure and record eye drop cap removal to improve eye drop-taking behavior. The iD2 addresses the Institute of Medicine’s priority topic to compare the effectiveness of new remote monitoring technologies to usual care in managing chronic disease.